Novel anti-HIV compounds targeting the HIV-1 matrix protein

ABSTRACT
Because of the emergence of drug-resistant strains and the cumulative toxicities associated with current
therapies, demand remains for new inhibitors of HIV-1 replication. The HIV-1 matrix protein (MA) is an
essential viral component with established roles in the assembly of the virus. Using a combination of virtual
screening, surface plasmon resonance analysis, and antiviral testing, we were the first to identify small drug-
like molecules that bind to the HIV-1 MA protein and that possess broad-range anti-HIV properties. Combining
computer-aided drug design techniques and medicinal chemistry, we have designed and synthesized next
generation compounds that interact with HIV-1 MA and inhibit the virus. Our current lead compound, MTI-14
binds to HIV-1 MA (as judged by SPR and NMR), has low toxicity, and has mid-micromolar potency. Moreover,
MA mutant viruses display reduced sensitivity to MTI-14, demonstrating that the antiviral action of the
compound is mediated through disruption of the functions of MA. Excitingly, preliminary mechanism-of-action
studies also suggest that MTI-14 functions by blocking HIV-1 Env incorporation into new viral particles. We
propose to further optimize this MA-targeted inhibitory compound to potencies that are clinically relevant, while
using these inhibitors as molecular tools to dissect the biology of the MA protein in the HIV-1 replication cycle.
The goals of the proposed studies will be accomplished by three discrete but highly integrated specific aims. In
Aim 1, the leads will be optimized through structure-guided design and medicinal chemistry approaches, their
kinetic properties including on- and off-rates and binding affinities (KD) will be measured, and their binding site
verified by chemical shift NMR and competitive fluorescent polarization assays. In addition, novel chemotypes
will be sought using ligand-based screening approaches. In Aim 2, the antiviral potency and breadth of the
leads will be assessed. Evaluation of their toxicity will be performed in parallel. In Aim 3, we will perform
detailed mechanism-of-action studies, generate resistance mutants, and determine the structures of the new
inhibitors in complex with MA using crystallographic and nuclear magnetic resonance methods. The data from
these studies will be used in designing potent next-generation MA-targeted inhibitors with high genetic barriers
and unique modes of action. Such compounds will also serve as novel molecular probes for HIV-1 MA
functions.

Public health relevance
Project Narrative Despite the success of antiretroviral drug regimens, new targets for inhibition of HIV-1 replication are highly desirable, and new drugs are needed to combat the rising problem of drug resistance. The studies proposed in this application will optimize and characterize a new class of compounds that are targeted at the HIV-1 matrix (MA) protein and that act via novel mechanisms. The compounds generated within this proposal have the potential to serve as templates for novel anti-HIV agents while also providing unique reagents with which to dissect the basic biology of HIV-1.